CANCER CENTER

The Dana-Farber Cancer Institute is an independent, federally dcsignated, Comprehensive Cancer Center affiliated with the Harvard Medical School. The aims of the Institute can be summarized as follows: (a) to develop and maintain clinical and laboratory research programs of high quality related to the biology, cause and prevention, diagnosis and treatment of cancer; (b) to provide total care for cancer patients on an interdisciplinary basis and in association with neighboring institutions; c) to serve as the major cancer center in the Harvard-Longwood medical area and to play a leadership role for cancer research and patient care in New England providing expertise in cancer diagnosis and treatment; (d) to add to the total oncology resources of the medical community in terms of available staff, facilities and expertise; (e) to participate in the teaching and training of medical students, house staff, fellows and graduate students and in the continuing education of practicing physicians and other health professionals, and to provide post-doctoral research training. To maintain these activities, the present application requests renewal of the Institute's Cancer Core Support Grant.